Integrated Clinical and Basic Endocrinology Research

The overall goal of the Integrated Clinical and Basic Endocrinology Research Training Program (ERTP) is to train capable, creative, and thoughtful adult and pediatric endocrinologists for careers in modern endocrine investigation. At the completion of training, it is anticipated that trainees will be able to independently initiate investigations into areas important for understanding of endocrine disorders or of health disparities and economics in populations with endocrine disorders.

Public health relevance
Diseases of the endocrine system constitute major public health problem in the US and worldwide. The objective of this Training Program is to prepare physician scientists to pursue research careers addressing mechanisms and treatment of human disease with focus on the endocrine system. Trainees from this Program will identify disease mechanisms, and develop and implement new effective treatments, whose applications will improve human health.